uORF-mediated Translational Control of Cardiac Transcription Factor Expression

Short peptide-encoding sequences in the 5' untranslated region of messenger ribonucleic acids (mRNA),
called upstream open reading frames (uORFs), are widespread in ~50% of human mRNAs. Translating
these uORF sequences reduces the protein output of an mRNA main open reading frame (mORF). Our
bioinformatic analysis of human and mouse ribosome profiling databases uncovered a group of cardiac
mRNA transcripts containing translated uORFs, such as transcription factors, including GATA4.
Biochemical analysis suggests that stabilizing the double-stranded RNA (dsRNA) structure downstream of
the start codons of these peptide-encoding sequences enhances their translation, thereby inhibiting the
translation of mORFs. This translational inhibitory mechanism is mitigated by DEAD-box RNA helicase
DDX3X that unwinds dsRNA and inactivates uORF. Genetic depletion of GATA4 uORF activity using
CRISPR-Cas9 mediated genomic editing of the start codon in human embryonic stem cells (ESC) provides
evidence of uORF-mediated regulation of mORF translation and cardiomyocyte (CM) hypertrophy. In
addition, an established CRISPR-Cas9-derived uORF start codon mutant knock-in mouse model shows
spontaneous cardiac hypertrophy and will be used to characterize CM hypertrophy at baseline and under
stress conditions. Based on our discovered molecular mechanism of DDX3X-regulated, dsRNA-dependent,
uORF-mediated translational inhibition of mORF, we have developed two types of antisense
oligonucleotides (ASOs) that can either enhance or reduce uORF translation by strengthening or disrupting
dsRNA structures. The uORF-enhancing ASO locks the dsRNA structure and activates translation of the
uORF, thereby reducing GATA4 mORF protein expression in human CMs. Treatment of mouse
cardiomyopathy models with uORF-enhancing ASO reduces GATA4 protein expression, antagonizes
cardiac hypertrophy, and restores cardiac function. Based on our findings, we hypothesize that cardiac
transcription factor mRNA uORF-dsRNA element acts as a switch for translational control of mORF,
regulating cardiac hypertrophy, and can be targeted by ASOs to modulate mORF protein translation and
cardiac hypertrophy. We will focus on 3 Specific Aims. Aim 1. Elucidate mRNA structural elements and
their interplay with the GATA4 uORF for regulating mORF translation. Aim 2. Determine the biological role
of the GATA4 uORF in genetic knock-in mouse models and primary CM cell culture systems. Aim 3.
Develop proof-of-concept translation-manipulating ASOs targeting the GATA4 uORF for short-term anti-
hypertrophy intervention. These studies will provide novel insights into translational control mechanisms
in cardiac biology. This project will promote novel therapeutic approaches (targeting uORF-dsRNA
elements) to regulate cardiac hypertrophy. Our mechanism-based design of translation-manipulating
ASOs can serve as a proof-of-concept model to apply to different pathogenic mRNA targets.

Public health relevance
Project Narrative: Heart disease is the leading cause of morbidity and mortality in the United States and cardiomyocyte hypertrophy is a major hallmark in disease progression. Understanding of the fundamental mechanism of gene regulation at the level of protein synthesis in cardiomyocytes in normal physiology and during cardiomyocyte hypertrophy will provide novel insights for preventive and therapeutic interventions of heart disease. In this proposal, we will investigate the function and mechanism of translation control mediated by a novel double-stranded RNA element in synergy with upstream open reading frames, which is required for maintaining cardiac physiological homeostasis. These studies will provide proof-of-concept evidence to support developement of novel therapeutic targets and RNA-based modality for treating cardiac pathological hypertrophy.